Physiological Ramifications of Chorionic Somatomammotropin Deficiency

PROJECT SUMMARY
Impaired placental development and function is an underlying etiology of intrauterine growth restriction (IUGR),
which is a significant cause of infant mortality and morbidity, predisposing these individuals to adult metabolic
disease, including Type 2 Diabetes. Unfortunately, there are still many aspects of the progression of human
pregnancy that are not understood, especially in regards to the causation and progression of pregnancies
complicated by impaired placental development. Many of these questions cannot be directly addressed in
humans, predicating the need for relevant animal models. It is our long-term goal to determine the causes
behind impaired placental function, and how this manifests itself in IUGR. To this end, we developed in vivo
lentiviral-mediated RNA interference methodologies in order to assess the function of genes expressed by the
placenta in sheep, an animal model that allows the study of placental and fetal physiology under steady state
non-anesthetized/non-stressed conditions. Chorionic Somatomammotropin (CSH) was discovered >50 year
ago, and is one of the most abundant proteins secreted by the placenta, yet there is no direct evidence
defining its function. CSH-deficient pregnancies, generated by lentiviral-mediated RNA interference in sheep
exhibit significant placental and fetal growth restriction near-term, and the fetal growth restriction is apparent at
the end of the first one-third of pregnancy. The near-term fetuses in our CSH-deficient pregnancies are
hypoinsulinemic and hypo-IGF1. Placental expression of nutrient transporters, especially SLC2A1 (GLUT1) is
diminished early in pregnancy, and both SLC2A1 and SLC2A3 (GLUT3) are significantly depressed near-term,
suggesting that the IUGR resulting from CSH deficiency may be a consequence, at least in part, from impaired
placental nutrient transfer. Herein, we will address our central hypothesis that CSH has a dual mechanistic
role in regulating fetal growth: 1) it stimulates placental development and nutrient transport to the fetus, and 2)
it also directly stimulates fetal tissue paracrine IGF1 and 2 expression in early to mid-gestation and circulating
(endocrine) IGF1 and insulin production in late-gestation. This hypothesis is supported by our compelling
preliminary data and the ability to study the ramifications of CSH deficiency under steady state non-
anesthetized/non-stressed conditions. We propose three Specific Aims. In Aim 1 we will test the hypothesis
that early- and mid-gestation IUGR observed in CSH-deficient pregnancies results from impaired placental
glucose transfer to the fetus and impaired stimulation of fetal tissue IGF1 and 2 expression. In Aim 2 we will
test the hypothesis that late-gestation IUGR observed with CSH deficiency results from impaired placental
glucose transfer to the fetus and lower fetal circulating insulin and IGF1 concentrations. In Aim 3 we will test
the hypothesis that late-gestation CSH deficiency causes impaired in vitro and/or in vivo hepatocyte and islet
secretion of IGF1 and insulin, respectively. The combination of these innovative and robust studies will
significantly impact on our understanding of in vivo placental-fetal interactions that result in IUGR.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT Functional placental insufficiency is a major cause of intrauterine growth restriction, leading to infant morbidity and mortality, and to development of metabolic disease during childhood or later in life. In this proposal, we will use a novel combination of approaches to create IUGR pregnancies as a result of CSH-deficiency, and thoroughly examine the impact of CSH-deficiency on placental function and fetal physiology in vivo. This work will enhance our understanding of how functional placental insufficiency results in a significant pregnancy complication.